Multidisciplinary Training Program on Neuropsychiatry Administrative Supplement

Project Abstract
NEUFIN (Neuroscience in First Nations) is a unique advanced research training and mentoring
program focused on the indigenous minorities of South America, one of the most underserved
populations in the globe. Over the past eight years we completed three cycles of advanced training -in
the context of an international master of science degree - and capacity development, for scholars and
faculty of First Nations from Bolivia and Peru. With the support of this administrative supplement we
will expand capacity building and provide all of the course work leading to a diplomate in neuroscience
for seven additional Quechua neuroscientists on clinical research applications of neuroimaging,
genetics, epidemiology, neuropsychology and neuromodulation. We will also create personalized
training environments for the new scholars and incorporate them to our innovation ecosystem online to
support capacity and career development for Quechua neuroscientists after completion of their initial
degree. The Training Program consists of a single component:
1. Diplomate Graduate Program in Neuroscience for First Nations to train Quechua speaking scientists
for multidisciplinary research studies in clinical and translational neurosciences, epidemiology,
imaging, and genetics research. Support includes all tuition towards a Diplomate in Neuroscience based
at Universidad Peruana Cayetano Heredia.
2. Ecosystem of Innovation in First Nations to provide a personalized learning, training and mentoring
environment for a diverse group of scientists, focused on precision and personalized medicine
approaches to neuropsychiatric and neurodegenerative diseases in First Nations. Scholars will continue
fruitful participation and development of their research capacity after graduation taking full advantage
of online resources, tools and interpersonal connectivity. NEUFIN provides an ecosystem for advanced
learning, innovation, collaboration and implementation of translational research in chronic brain
disorders, bringing together clinicians and researchers from multiple partner institutions. NEUFIN will
follow the described model by building an ecology of innovation with a strong focus on translational
and personalized medicine strategies through open and dynamic learning conversations inside and
outside the group through regular seminar series and the Fall Research Institute, and with a strong
incentive and recognition system based on funding for pilot studies.
3. To ensure recruitment of trainees from multiple Andean communities in two different countries, who
will remain as researchers in their home institutions we will implement several intersecting strategies.
4. To interact with other Fogarty Training Programs. via web based electronic communication efforts
supported by an FIC/ARRA grant to the Director to share curriculum and training experiences to
enhance our programs

Public health relevance
Project Narrative NEUFIN (Neuroscience in First Nations) is a unique advanced research training and mentoring program focused on the indigenous minorities of South America, one of the most underserved populations in the globe. Over the past five years we completed 3 cycles of advanced training -in the context of an international master of science degree - and capacity development, for scholars and faculty of First Nations from Bolivia, Peru and Argentina. We will continue to build capacity and train Quechua neuroscientists on clinical research applications of neuroimaging, genetics, epidemiology, neuropsychology and neuromodulation. We will also create personalized training environments and an innovation ecosystem online to support capacity and career development for Quechua neuroscientists after completion of their initial degree